CommunityRx-Dementia + Peer Navigation (CRxDpeer): A Real-World Implementation and Effectiveness Study of an IT-Based Social Care Intervention

PROJECT SUMMARY/ABSTRACT
In 2022, more than 11 million Americans, half of whom were 50 or older, provided more than 18 billion hours of
unpaid care for people with dementia. Many caregivers have no formal training and limited support. The White
House, along with the Alzheimer's Association, the National Institute on Aging and others, is calling for urgent
attention to the health and well-being of the fast-growing population of dementia caregivers, with heightened
concern for caregivers living in historically marginalized communities. Scalable, evidence-based, solutions
leveraging existing assets are urgently needed to meaningfully reach all caregivers. Our approach to addressing
these unmet needs, CommunityRxDpeer, is an information technology-based, low-intensity, health system-
initiated community resource navigation intervention delivered to caregivers by peer caregiver navigators
remotely over time. Essential components include education about common social, including caregiving needs,
activation of personalized community resource information and ongoing navigation-focused support. The
CRxDpeer intervention components are informed by evidence-based “processes” identified in the Grey et al.
Self- and Family Management Framework that are known to promote desirable health outcomes among people
living or caring for others with chronic health conditions, including dementia. Prior CommunityRx trials have
successfully deployed community members, clinicians and researchers to deliver the intervention in real-world
and research settings with positive outcomes in a diversity of populations. In this pragmatic trial, experienced
and willing dementia caregivers from the CRxDementia cohort (2020-24) will be recruited and trained as peer
navigators to deliver CRxDpeer. Using a hybrid effectiveness implementation design with a double-blind RCT,
we will evaluate the effectiveness of CRxDpeer versus usual care on caregiver health and well-being, healthcare
utilization and social care outcomes. In parallel, we will evaluate the adoption, fidelity and cost of CRxDpeer and,
using mixed methods, characterize perceived mechanisms of impact on caregivers delivering and receiving
CRxDpeer. The specific objectives are to demonstrate that CRxDpeer can be delivered in the real world with
fidelity and to assess the effectiveness of this approach on important outcomes. Resource referral and peer
support IT platforms deployed for intervention delivery are already in commercial use, paving a viable path to
replication and scale as a stand-alone or adjunct to other caregiver interventions, like the Center for Medicare &
Medicaid Guiding an Improved Dementia Experience (GUIDE) Model test, which aims to enable people with
dementia to age at home by supporting family caregivers with education and resources. CRxDpeer has the
potential to improve the health and well-being of millions of dementia caregivers and their care recipients by
meaningfully connecting them to vital social and caregiving resources and creating opportunity for willing and
experienced caregivers to support with others.

Public health relevance
PROJECT NARRATIVE Policymakers, public health officials and advocates are calling for urgent attention to the health and well-being of the fast-growing population of dementia caregivers. The specific objectives of the CommunityRxDpeer study are to assess the effectiveness of a community resource navigation intervention, delivered by peer caregivers, for promoting the health and well-being of people affected by dementia. This proposal responds to NIH research priorities related to supporting the “health, function, and well-being” of persons with Alzheimer’s Disease and Related Dementias and their caregivers, including calls for interventions that address emotional, physical, and financial stress of caregivers, especially those that address the needs and challenges of diverse individuals.